Moonlighting in Mitochondria: A Non-Canonical Role for Cardiac Troponin I in Inherited Cardiomyopathies

PROJECT SUMMARY: Cardiovascular disease is a leading cause of death, and mitochondrial dysfunction is
implicated in the pathogenesis of cardiomyopathy. Cardiac troponin I (cTnI) is a regulator of myocyte contraction,
and mutations in cTnI lead to hypertrophic, dilated, and restrictive cardiomyopathies and sudden death. It is not
known why cTnI mutations have such heterogeneous phenotypes, and there are no targeted therapies for
cardiomyopathies caused by cTnI mutations. cTnI is regulated by phosphorylation and proteolytic truncation. We
recently showed that selectively inhibiting phosphorylation of cTnI by delta protein kinase C (δPKC) during
myocardial infarction using a lab-designed peptide inhibitor attenuates cardiac injury and prevents mitochondrial
dysfunction. My preliminary data show a novel role of cTnI in inhibiting mitochondrial function, and a therapeutic
benefit of preventing cTnI’s binding to mitochondrial ATP synthase using a peptide inhibitor in ischemic injury.
The objective of this application is to identify the mechanisms by which cTnI inhibits mitochondrial function and
to define the interplay between cTnI mutations and mitochondrial dysfunction in genetic cardiomyopathies. My
central hypothesis is that cTnI phosphorylation and truncation directly inhibit mitochondrial function, and
mutations in cTnI impair mitochondrial function to cause cardiomyopathy. This hypothesis will be tested in two
specific aims: 1) Determine the effect of cTnI phosphorylation and truncation on mitochondrial function and 2)
determine the effect of pathogenic cTnI mutations on mitochondrial function. In Aim 1, I will test the effect of
recombinant cTnI with phospho-mimetic amino acid substitutions and N-terminal truncation on ATP synthase
binding/activity and mitochondrial respiration. I will also express phospho-mimetic cTnI and N-terminal truncated
cTnI in human induced pluripotent stem cell-derived cardiomyocytes (hiPSC-CM) to examine their effects on
mitochondrial structure/function and myocyte contractility/relaxation kinetics. In Aim 2, I will use hiPSC-CM and
transgenic mice with cTnI mutations to establish the effect of pathogenic mutations (causing hypertrophic, dilated
and restrictive cardiomyopathy) on mitochondrial function and test the effect of lab-designed peptide inhibitors
of cTnI phosphorylation and mitochondrial binding on mitochondrial function and contractility/relaxation in vivo.
This research is expected to identify a novel and therapeutically targetable role of cTnI in inhibiting mitochondrial
function and exacerbating myocardial remodeling in genetic cardiomyopathies. To successfully complete this
project, Dr. Elezaby’s educational goals include training in 1) rational drug design; 2) hiPSC-CM biology; 3)
genotype-specific mechanisms in genetic cardiomyopathies; 4) scientific communication; and 5) professional
development. His mentorship team includes world-renowned experts in mitochondrial and stem cell biology, drug
development, myocyte physiology, and cardiovascular genetics. His career development plan has been
designed to ultimately achieve his long-term goal of becoming a leading clinician-scientist investigating the
mechanistic underpinnings, therapeutic targets, and interplay between cardiac metabolism and cardiomyopathy.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will define a new and important role for a common protein in the pathogenesis of heart disease. This could have far-reaching implications in the development of therapies for genetic diseases of the heart. Thus, the proposed research is relevant to part of the NIH’s mission as it will seek basic discoveries relating to the cause of disease with applicability and potential for translation to clinical practice.